Development of a novel MYC inhibitor for cancer therapy

Summary
MYC proteins (including c-MYC, N-MYC and L-MYC) are critical oncogenic drivers that regulate multiple cancer
hallmarks. The evidence indicating that MYC is a critical oncogenic driver that regulates multiple cancer
hallmarks is compelling. Recent pan-cancer analyses of over 9,000 human cancers of various types found
amplification of MYC genes in ~28% of all cases. In addition, multiple mechanisms exist in tumor cells that
frequently lead to the upregulation of MYC mRNA and protein expression, leading to estimates that MYC proteins
are involved in at least 70% of all human cancers. MYC is particularly important in many therapy-resistant
cancers. For example, in castration-resistant prostate cancer (CRPC), c-MYC is amplified in 45% of cases, while
in late-stage neuroendocrine prostate cancer (NEPC), N-MYC is overexpressed in 40% of cases. In non-small
cell lung cancer, MYC promotes resistance to targeted therapies against EGFR and ALK. In hepatocellular
carcinoma (HCC), c-MYC protein is overexpressed in up to 70% of cases across all stages and grades,
implicating MYC as a prevalent, early and critical event in tumorigenesis. Thus, inhibiting MYC systemically with
a small molecule MYC inhibitor may lead to profound antitumor activity across many cancer types. However, to-
date, no small molecule MYC inhibitor has been developed into the clinic. To address this drug target, we set out
to develop small molecule MYC inhibitors suitable for development as a new therapeutic for cancer. After
implementing a novel in silico screen, novel in vivo testing, extensive medicinal chemistry optimization, and
thorough in vitro and in vivo characterization, we developed a novel series of direct small molecule MYC inhibitors
that demonstrate profound antitumor efficacy in MYC-driven models of prostate, liver, and other tumor types.
Our lead compound, MYCi606, completely eliminates HCC tumors in multiple syngeneic models and induces
immunological memory in HCC, suggesting this compound has the potential to be an extremely impactful new
therapeutic for liver cancer. Vortex Therapeutics has initiated IND-enabling studies on MYCi606. In this proposal,
we seek funding to continue this the development of MYCi606 by completing process development and GLP
toxicology studies. These efforts will position us for filing an IND in the near-term to study the first direct MYC
inhibitor in human clinical trials.

Public health relevance
Narrative The protein c-MYC (MYC) has been shown to be a key driver of many types of cancer, including prostate, lung, liver, breast, neuroblastoma, leukemia, and others. Although it is overexpressed in up to 70% of all cancers, to- date it has not been successfully drugged because MYC is a highly disordered protein and the belief that its inhibition will lead to general toxicity. We have developed the first direct small-molecule MYC inhibitors and propose to continue the pre-clinical development of our lead compound, MYCi606, to position ourselves for initiating the first human clinical trials of a direct small-molecule MYC inhibitor.